Trade-offs in human observer performance, image quality metrics, and patient dose

PROJECT SUMMARY/ABSTRACT
Computed tomography (CT) is an excellent diagnostic tool, but it exposes patients to ionizing radiation.
Consequently, an intensive, international effort has been made to reduce the radiation dose levels used for CT
imaging. Our long-term objective is to develop and validate highly translatable methods that can quantitatively
determine, for any specified diagnostic task, CT protocols that deliver the needed diagnostic accuracy at the
lowest patient dose. These methods will be, by design, applicable to any scanner model or imaging practice.
In our first competitive award period, we demonstrated that differences in scanners and scanning protocols
(e.g. doses, reconstruction algorithms) can lead to substantial variations in diagnostic performance. More
importantly, our multi-reader, multi-case observer studies demonstrated wide variations in performance among
readers (radiologists) and across different cases. These variations were larger than the variations due to dose.
Thus, a critical need exists to quantify and reduce these large variations in performance, but little work has
been done on this topic. Only after addressing this critical need can the CT community achieve a consistent
level of diagnostic performance over a wide range of scanners, cases, and readers and therefore safely adopt
lower doses in abdominal imaging – one of the most common CT applications. Thus, we now have a second
long-term objective, which is to reduce the variation in diagnostic performance that occurs due to case and
reader variation, even when appropriate CT protocols are used, and especially at lower doses.
The specific goals of this renewal application are to 1) validate that our methods for establishing lowest-
dose protocols (for a targeted level of performance) are indeed applicable to any scanner make or model; 2)
characterize case, lesion, and reader factors that lead to low diagnostic performance despite an otherwise
acceptable scan protocol; and 3) develop adaptive assessment and learning strategies to improve readers'
diagnostic skills across case and lesion type. We will accomplish these goals through three specific aims:
1. For multiple scanner models and protocols, demonstrate the success of our protocol optimization engine.
2. For abdominal CT, determine case, lesion, and reader predictors of radiologist diagnostic performance.
3. Develop adaptive learning and assessment techniques to address case and reader variability.
The proposed work is significant because it will use objective and quantitative metrics, as well as leading-
edge education and adaptive learning technology, to improve diagnostic performance and consistency in low-
dose CT imaging. This work is innovative because, for the first time, the case, lesion and reader features
leading to decreased diagnostic performance will be characterized and then mitigated with state-of-the-art
adaptive assessment and training techniques. The results of this work will allow any imaging facility to optimize
their dose levels without compromising the lifesaving diagnostic information obtained from CT.

Public health relevance
PROJECT NARRATIVE The lack of an evidence-based approach for determining the right CT imaging protocol for a particular task explains to a large degree the considerable variation in doses and image quality observed in clinical CT scanning. Moreover, recent evidence indicates that differences in observer performance were larger between radiologists than between different radiation dose levels. In this work, we will develop methods to guide optimization of dose and image quality for CT systems from multiple manufacturers, as well as a generalizable adaptive learning system to improve the diagnostic performance of radiologists for low-dose CT. The proposed research is relevant to public health because it will improve diagnostic performance and consistency in low- dose CT imaging, allowing imaging facilities to optimize their dose levels without compromising the lifesaving diagnostic information obtained from CT imaging.